Exploring exosomes in neurodevelopmental and neuropsychiatric diseases using brain organoids

PROJECT SUMMARY
Exosomes are small extracellular vesicles that mediate intercellular signaling in the brain without requiring
direct contact between cells. These vesicles are enriched with miRNAs, proteins, and lipids. Current evidence
for exosome signaling in the brain points toward their role in translational regulation, neurogenesis, synaptic
plasticity, and neuroinflammation, all of which have been implicated in several neurodevelopmental diseases.
However, changes in exosome signaling in mental disorders have yet to be explored.
Exosomes have been isolated from nearly all mammalian cell types, including cells in the central nervous
system such as neurons, astrocytes, oligodendrocytes, and microglia. Neurons and glia release exosomes in
vitro and in vivo. Trophic support from glial cells to neurons is thought to be conveyed by exosomes.
Exosome-mediated intercellular signaling has been implicated in neurodegenerative diseases such as ALS,
Parkinson’s disease, multiple sclerosis, and Alzheimer’s Disease as well as neurodevelopmental
disorders. More specifically, altered neuronal exosome signaling has been implicated in Rett syndrome, a form
of Autism Spectrum Disorder (ASD). However, the role of exosome signaling in ASD and other mental
disorders remains to be fully understood. The goal of this application is to explore whether exosome
content and numbers are altered in ASD. We have isolated exosomes from healthy control and patient brain
organoid cultures by differential ultracentrifugation and evaluated purified exosomes using transmission
electron microscopy, western blotting for biochemical markers, and nanoparticle characterization system. In
purified exosome fractions, we will first assess exosome proteomes and nucleic acid profiles that will be
compared between control and patient groups. In addition to content, there is also evidence suggesting that
exosome quantity is altered in disease states. To explore the role of neural exosomes in ASD, we propose to
determine 1) whether the proteome of exosomes isolated from ASD patient organoids differ from exosomes
derived from healthy control organoids (e.g., by comparing protein profiles with Tandem mass tag [TMT] liquid
chromatography [LC] mass spectrometry), 2) whether nucleic acid content in exosomes purified from ASD
patient organoids is altered in comparison to exosomes from control (e.g., by comparing RNA/miRNA profiles
with next-generation sequencing followed by bioinformatics), and 3) whether the quantity of exosomes
released from ASD brain cells is altered compared to control cells (e.g., by assessing the quantity of exosomes
in 2D neuronal or glial culture media using nanosight tracking analysis). Exosome analysis from organoids
and 2D cultures will serve as parallel strategies to delineate neural exosome content in health and
disease. Our studies have the potential to provide novel insights into the etiology of ASD. Identifying
alterations in amount or content of brain exosomes in ASD will reveal underappreciated modifications
in cellular communication during mental disease states.

Public health relevance
PROJECT NARRATIVE Exosomes are membrane-enclosed nanovesicles that are increasingly being recognized as important cell communication components transmitting proteins and RNAs. However, changes in exosome signaling in mental disorders have yet to be explored. This study aims to determine whether vesicular cargo and exosome quantity are altered in human stem cell models of ASD.